HEALTH APPLICATIONS OF THE NATIONAL INFORMATION

This research proposal aims to demonstrate the viability of secure clinical telemedicine on public telecommunication networks and show that its adoption as an integral part of an overall healthcare plan can result in cost savings and improved access to quality healthcare for rural populations. Three telemedicine applications will be developed to meet the needs of intensive care providers, mid-level providers and homecare patients. The applications will utilize strong encryption and authentication facilities, enabling authorized users to have secure access to electronic medical records and patient monitor data, and to confer with collaborating healthcare providers in the treatment of patients. These applications will undergo field trials at clinics and hospitals of partnering healthcare organizations. The assessment phase of the project includes evaluating the impact of these telemedicine applications on the delivery of healthcare, as well as evaluating measures to ensure the security and integrity of electronic patient information. We believe the results of our evaluation effort when widely disseminated will enable the healthcare industry embrace telemedicine as a key part of an overall healthcare system.